BRAIN CONNECTS: Rapid and Cost‐effective Connectomics with Intelligent Image Acquisition, Reconstruction, and Querying

SUMMARY
High-throughput connectomics is needed to generate the TB-, PB- and EB-scale wiring diagrams of mammalian
brains, but is limited to the few research institutes (e.g., Janelia, Allen, Max Planck) with sufﬁcient infrastructure.
As resource-rich as these institutes are, none are able to do a whole brain at nanometer scale on their own. The
failure to broaden participation to a larger community is an obstacle to scaling connectomics. We propose a new
and more affordable imaging strategy that will allow many more teams to engage in connectomics.
High-speed electron microscopes for connectomics – e.g., multibeam SEMs – are rare and prohibitively ex-
pensive. More common single-beam SEMs have sufﬁciently high spatial resolution, but are prohibitively slow
for connectomics. We plan to increase the speed of single-beam SEM systems to the speed of multibeam
SEMs without substantially increasing cost. Our strategy adds artiﬁcial intelligence to SEM architecture to re-
duce the number and dwell time of pixels that need to be imaged at high-resolution without adversely affecting
“segmentability”. With new software and standard computer hardware, we can turn single-beam SEMs into intel-
ligent, powerful devices at negligible cost. We demonstrated a proof-of-concept of a smart scanning system that
we engineered into a single-beam SEM. The modiﬁed SEM acquires a low-resolution/low-dwell time image of a
brain slice at high speed. It then uses ultrafast ML algorithms to extract most of the wiring from these images,
while at the same time identifying in real time those salient pixels that should be rescanned to improve signal-to
noise in the ﬁnal wiring diagram. We have achieved >10-fold speedup in image acquisition, and plan to increase
the rate signiﬁcantly more.
A signiﬁcant scale-up in the rate of connectomics demands comparable improvements in image processing
(stitching, alignment, and segmentation). We have built computationally more efﬁcient methods for aligning and
segmenting connectome datasets. We will integrate these methods into a cloud-based platform that will allow
researchers without signiﬁcant computational infrastructure or expertise to process connectomics datasets. All
data products and capabilities will be publicly accessible through BossDB.
In summary, this integrated research program will scale connectomics to a much larger neuroscience
community.

Public health relevance
Project Narrative We will increase the speed of single-beam SEM systems for connectomics by 10-100 fold without substan- tially increasing cost. We will build computationally efﬁcient methods for aligning and segmenting connectome datasets in a cloud-based infrastructure (BossDB). We will validate the faster pipeline for connectomics and create tools for collaborative connectomics where many individual groups are able to complete portions of larger mammalian brains.